TCR Targeting Antibodies for the Treatment of T cell Cancers

Project Summary
Antibody-mediated targeted immunotherapies are highly effective in killing cancer cells. T cell leukemias
and lymphomas, collectively known as T cell cancers, affect ~100,000 patients worldwide each year. Relapsed
T cell cancers respond poorly to aggressive chemotherapy with a 5-year survival between 7% to 38%. Thus, T
cell cancers particularly warrant antibody-mediated targeted immunotherapy to improve patient outcomes.
However, developing a T cell cancer targeting immunotherapy is challenging as the immunotherapy will have to
preserve enough healthy T cells to maintain a functioning immune system. T cells express the T cell receptor
(TCR) on the cell-surface. Although all T cells express TCR, they can be distinguished based on the TCR beta
chain constant region (TRBC) which is derived from one of two gene segments, TRBC1 or TRBC2. I led a team
that demonstrated that in healthy T cell populations, about 45% of cells express TRBC1 while the other 55%
express TRBC2. However, clonal T cell cancers express either TRBC1 or TRBC2 (Paul et al., Sci. Transl. Med.
2021). Thus, I hypothesize that antibody-mediated specific TRBC1 or TRBC2 targeting will eradicate the clonal
T cell cancers while preserving half of the healthy polyclonal T cell population. I also developed a TRBC1-
targeting bispecific antibody (αTRBC1) that selectively kills TRBC1+ T cell cancers (and TRBC1+ healthy T cells)
while preserving the healthy TRBC2+ T cells in vitro. These in vitro observations will require confirmation in
animal models before initiation of future human clinical trials. For Aim 1, I will determine the in vivo activity of the
αTRBC1 bispecific antibody. I will test the ability of αTRBC1 antibodies to induce tumor regression in multiple
mouse models of T cell cancers. I will then examine if the remaining healthy TRBC2+ T cells retain all of the
immune cell subsets required for a functioning immune system. I will also test if therapeutic pressure from the
αTRBC1 bispecific antibody will give rise to a low TCR expressing T cell population that will be resistant to
therapy. For Aim 2, I will test feasibility of TRBC2-targeting on T cell cancers. As a TRBC2-targeting antibody is
currently unavailable, I will use phage display to develop TRBC2-specific antibodies. I will then test the
cytotoxicity of TRBC2 targeting antibodies in vitro and in multiple mouse models of T cell cancers. Our TRBC-
directed antibodies will fill an unmet need for the treatment of T cell cancer patients. The proposed in vivo and
mechanistic studies will provide the pre-clinical validation required for the initiation of an early-phase human
clinical trials that will test the safety and efficacy of TRBC1- and TRBC2-targeting antibodies.
My long-term goal is to become an independent laboratory-based physician-scientist focusing on
developing novel therapeutic approaches for T cell cancers. Through this proposal, I will also acquire the
research skills and career experience needed to reach this goal. These skills will be critical to the development
of a relevant, impactful translational research program in human T cell leukemias and lymphomas.

Public health relevance
Project Narrative Few treatment options are available for T cell cancers that affect ~100,000 patients worldwide each year. The current proposal will generate a type of immunotherapy using new antibodies that specifically kill the T cell cancers and retain enough healthy T cells to maintain a functioning immune system. This immunotherapy may improve patient outcome and limit side effects associated with traditional chemotherapies.